Regulation of gonadotropin secretion during undernutrition by a brainstem-hypothalamic neural pathway

PROJECT SUMMARY/ABSTRACT
The overall goal of this research is to understand how stress disrupts the ovarian cycle. Chronic undernutrition
is a type of metabolic stress that impairs reproduction across species, and in women is implicated in the
development of functional hypothalamic amenorrhea, an anovulatory disorder resulting from inadequate
gonadotropin secretion. Although the tight coupling of energy balance to reproductive capacity is recognized in
principle, the neuroendocrine loci and molecular mechanisms that mediate ovarian cycle dysfunction
during undernutrition remain poorly understood. In females, ovulatory cyclicity is dependent on two
populations of kisspeptin (Kiss1) neurons within the hypothalamus that coordinate gonadotropin-releasing
hormone (GnRH) and luteinizing hormone (LH) pulses and generation of the preovulatory GnRH/LH surge.
Disruption of either arcuate Kiss1 (ARCKiss1) control of LH pulses or anteroventral periventricular Kiss1
(AVPVKiss1) control of the LH surge would be anticipated to impair ovarian cyclicity in females. Our preliminary
studies demonstrate that chronic undernutrition rapidly disrupts ovarian cyclicity in female mice via
impairment of both pulsatile LH secretion and the LH surge. We show that these inhibitory effects on the
ovarian cycle are recapitulated by activation of brainstem A2NE neurons or via central administration of urocortin
2 (UCN2), a neuropeptide that specifically activates corticotropin-releasing hormone receptor 2 (CRHR2). Our
observations that antagonism of CRHR2 or knockdown of CRHR2 in Kiss1 cells diminishes reproductive
suppression in response to undernutrition or A2NE activation provide the foundation to test this neural pathway
mediating the effects of undernutrition on reproductive neuroendocrine function. Currently it is not known how
undernutrition disrupts the cycle or the neural processes controlling pulsatile or surge LH secretion. We propose
to fill this gap by testing the overall hypothesis: Chronic undernutrition disrupts the ovarian cycle and fertility
via activation of a NE – UCN2 – Kiss1 neural pathway that impairs two modes of LH secretion: LH pulses
and the preovulatory LH surge. Aim1 will utilize a genetic knockout approach to investigate the role of CRHR2
within Kiss1 cells as a mediator of disrupted cycles, LH pulses, and the LH surge during chronic undernutrition.
Aim 2.1 will utilize a chemogenic approach to test the sufficiency of this brainstem population to impair the ovarian
cycle, inhibit AVPVKiss1 control of the LH surge, and disrupt ARCKiss1 control of LH pulses. Aim 2.2 will determine
the necessity of A2NE signaling for disrupted ovarian cyclicity and impaired neural pathways underlying pulsatile
and surge LH secretion. This project will employ powerful physiological, anatomical, molecular and transgenic
tools to advance our knowledge of integrated stress responses and the regulation of gonadotropin secretion.
Results from this proposal will provide enhanced understanding of the metabolic control of reproduction that may
influence the management and treatment for anovulatory disorders resulting from negative energy balance. All
necessary animal models and methods are in place to complete these studies.

Public health relevance
PROJECT NARRATIVE Metabolic stress is considered a major factor in the development of menstrual cycle disorders, amenorrhea and infertility in females. Using genetic, pharmacologic and molecular approaches, this proposal tests the hypothesis that a brainstem – hypothalamic neural pathway mediates the effect of chronic undernutrition on ovarian cyclicity in females. Results from this proposal will contribute enhanced understanding that may influence the management and treatment for anovulatory disorders resulting from negative energy balance.